New models for interrogating the impact of sex chromosomes and sex hormones on glioblastoma

PROJECT SUMMARY
There is a sex disparity seen in cancers throughout the body where males have both a higher incidence and
a higher mortality than females. This phenomenon is seen in glioblastoma (GBM) that comprises over 50% of
brain tumors and are characterized by resistance to therapies and a dismal prognosis. This is not only true for
adults, but children as well, suggesting that factors other than the effects of sex hormones may be playing a role
in this phenomenon. Because enhanced nutrient consumption and metabolism are critical to enhanced
tumorigenesis and its effect on poor patient outcomes, our group investigates the effects of biological sex on
cancer metabolism as a driver for the sex disparity where male tumors engage in more carbohydrate and amino
acid metabolism concomitant with higher PI3K-Akt-mTOR signaling that are associated with faster tumor growth
and worse survival. Intriguingly, the metabolic sex differences that we observe in human and rodent GBM are
also present in cell lines, suggesting a cell-intrinsic component. This could be due to direct sex chromosome
effects and/or epigenetic tissue patterning effects from exposure to in utero gonadal sex hormones.
Unfortunately, laboratory models for rigorous mechanistic sex differences research in GBM are lacking. This
proposal will develop novel GBM models to address the hypothesis that sex chromosomes and sex hormones
are both drivers of GBM phenotype, measured by proliferation and cellular metabolism. In the first Aim, we will
use the Four Core Genotypes (FCG) mouse model to define the contributions of sex chromosomes and
organizational effects of in utero exposure to sex hormones to astrocyte metabolism before and after
mesenchymal GBM transformation. First, wildtype FCG astrocytes will be harvested from P1 pups and assayed
for sex differences across key metabolic and signaling pathways important for cancer. CRISPR-Cas9 of FCG
astrocytes will then be used to generate the mesenchymal subtype GBM models Nf1-/-Tp53-/- (proof of principle
with strong sex-specific phenotype) and Pten-/-Tp53-/- (to test effects of Pten deletion on sex differences in PI3K-
Akt-mTOR signaling). Cell lines and allografted tumors will be assayed for growth, metabolism and gene
expression. Novel, advanced diffusion MR imaging from our lab will be used to noninvasively assay changes in
the tumor microenvironment. In the second aim, we will develop human induced pluripotent stem cell (iPSC)
models to evaluate the contributions of sex chromosomes to cellular differentiation and mesenchymal GBM
transformation. NF1-/-TP53-/- transformed NPC will then be generated from iPSC using published methods
developed by our team. NF1-/-TP53-/- NPC will be orthotopically xenografted into mice. Cell lines and tumors will
be assayed for growth, metabolism and gene expression including imaging-based growth and tumor
microenvironment assessment as above. This research proposal is innovative because it develops the
necessary models to investigate the effects of biological sex on cancer biology and patient outcomes. This R21
presents a clear path to a future R01 that will involve the expansion of cell and animal models to study sex
chromosome and gonadal effects on GBM, advancing the NIH’s initiative to incorporate sex as a critical biological
variable.

Public health relevance
PROJECT NARRATIVE Glioblastoma (GBM) is an extraordinarily aggressive cancer with a dismal survival. The incidence of GBM in males is twice as high as females and males typically have more aggressive disease but the reasons for this are unknown. This project develops new models to study the effects of sex chromosomes and sex hormones in brain tumors using (i) mice with Four Core Genotypes (FCG) genetics to separate sex chromosome from sex hormone effects and (ii) isogenic human induced pluripotent stem cells (iPSC) with XX and XY sex chromosomes to study sex chromosome effects. OMB No. 0925-0001/0002 (Rev. 01/18 Approved Through 03/31/2020) Page Continuation Format Page